A library-based prevention intervention for adolescents affected by parental drug use

PROJECT SUMMARY
Drug dependence is one of the most serious national public health problems, affecting millions of individuals
and their families. African-American families experience disproportionate rates of negative health and social
consequences of drug abuse, even though they use drugs at rates comparable to or lower than those of
European-Americans. African-American children affected by parental drug use are at an extremely high risk
for a range of problems throughout childhood and into adulthood. Effective implementation of integrated
prevention interventions is critical to reducing the burden of substance use disorders and directly improving
public health. This Career Development Award (K01) has allowed me to obtain the additional mentoring,
training and skills to achieve my long-term career goal of becoming an independent investigator with
expertise in designing, implementing and evaluating prevention interventions for vulnerable African-
American adolescents through partnerships with public libraries. My three training objectives were to: (1)
obtain comprehensive training in the etiology of substance use among urban African-American families; (2)
develop expertise in the theoretical underpinnings, processes and mechanisms of intervention development
and adaptation; and (3) become proficient in implementing and evaluating randomized clinical trials using
advanced statistical techniques. I achieved these goals through didactic experiences, participation in
professional conferences, directed readings, and experiential learning opportunities under the mentorship of a
team of experts in relevant fields of study. This mentoring and training directly contributed to the
proposed research, which was designed to prevent substance use and sexual health risk behaviors
among urban Black adolescents (ages 13-16) affected by parental drug use through partnerships with
public libraries. There were three specific aims laid out in the research plan to: (1) identify the opportunities
and barriers for engaging adolescents with a drug-abusing parent in prevention programs and health services;
(2) adapt the evidence-based intervention, Focus on Youth with Informed Parents and Children Together
(FOY+ImPACT) to be a virtual, library-partnered, targeted intervention for adolescents affected by parental
drug use and (3) conduct a pilot study to assess the feasibility and initial efficacy of the adapted library-based
prevention intervention for adolescents affected by parental drug use. Findings from the proposed research will
lay the foundation for collaborative efforts that facilitate libraries’ provision of evidence-based prevention
interventions to vulnerable youth, including, but not limited to, adolescents affected by parental drug use,
homeless youth, as well as youth involved in the foster care and juvenile justice systems. This Administrative
Supplement will allow me to complete the final research aim, which was significantly impacted by the COVID-
19 pandemic related closures. During this extended K01 award period, I will complete the pilot and submit a
R01 proposal to NIDA to conduct a Phase II randomized controlled trial of the adapted intervention.

Public health relevance
PROJECT NARRATIVE African American adolescents affected by parent are at an extremely high risk for a range of problems. Virtual partnerships with libraries are an ideal way to offer prevention services to this population because they are flexible, inclusive and easily accessible when face to face interactions are restricted. Findings will lay the foundation for collaborative efforts that facilitate libraries’ provision of prevention interventions to vulnerable youth, including those with incarcerated parents, parents who suffer with a mental health condition, as well as those who experience abuse or violence in their homes.